Identifying the targets of virus-induced PARPs during SARS-CoV-2 infection

PROJECT SUMMARY
Coronaviruses (CoVs) are a large class of positive-strand RNA viruses that are capable of causing severe
human disease and death, as is exemplified by the pandemic outbreak of SARS-CoV-2. The innate immune
response to coronavirus infection includes a battle between poly-ADP-ribose polymerases (PARPs) and the
coronavirus macrodomain (Mac1), which add and remove ADP-ribose from proteins, respectively. In the
absence of Mac1 enzyme activity, CoVs replicate poorly in the face of the innate immune response and cause
little to no disease in several animal models of infection, including SARS-CoV-2. These results demonstrate
the power of PARP-mediated ADP-ribosylation to limit CoV-induced disease and support our central
hypothesis that PARPs target host and viral proteins, and that the post-translational modification of these
targets (MARylation) induces an antiviral state that limits virus replication. Despite the clear importance of
PARP enzymes in driving the outcome of a CoV infection, a large gap in knowledge remains as to exactly how
this battle plays out during CoV infections, most notably i) what PARPs are heavily involved in this battle; and
ii) what cellular or viral proteins are ADP-ribosylated during infection. Functional redundancy, similar NAD+
binding sites, low protein abundance, and viral enzymes that reverse their effects have made it challenging to
identify direct targets of individual PARPs during coronavirus infection.
The objective of this proposal is to identify specific ADP-ribosylated targets of PARPs during a SARS-CoV-2
infection that will uncover novel mechanisms of virus restriction. This objective will be resolved with the
following specific aims: 1) Identify PARPs proteins that are expressed during and impact SARS-CoV-2
infection, and 2) Identify viral and cellular PARP targets using chemical genetics and proximity labeling. This
work is innovative because we will apply, for the first time, NAD+-based chemical proteomics, chemical
genetics, and BioID proximity labeling to uncover the specific targets of of MARylating PARPs that impact
SARS-CoV-2 infection. Furthermore, we have a unique tool, a virus that lacks the ability to counter PARP
activity, to aid in our identification of physiologically relevant PARP target proteins. Our rationale is that
identifying the targets of individual PARPs during SARS-CoV-2 infection will define novel mechanisms of virus
restriction that will dramatically expand the landscape of ADP-ribosylation and how it can impact virus
replication. Together, with our combined expertise in chemistry, PARP/ADP-ribose, and CoV biology, we are
poised to address these challenges and make seminal discoveries describing novel targets of PARP-mediated
ADP-ribosylation and how they can drive antiviral innate immune responses during SARS-CoV-2 infection. We
anticipate identifying dozens of ADP-ribosylated proteins during infection, which will alter the landscape of how
PTMs, outside of phosphorylation or ubiquitination, can impact the outcomes of virus infections, and will
provide new avenues for antiviral therapy.

Public health relevance
PROJECT NARRATIVE The mammalian anti-viral response utilizes several post-translational modifications (PTMs), like phosphorylation, to quickly alter signaling pathways or directly inhibit viral proteins. ADP-ribosylation is a PTM that controls the outcome of a coronavirus infection; however, little is known regarding how it restricts virus replication at a mechanistic level. The primary objective of this proposal is to identify ADP-ribosylated proteins during SARS-CoV-2 infection with the goal of developing a better understanding of the mammalian anti-viral response that will provide new avenues for anti-viral therapies.